Interpreting Functional Cochlear Implant Outcomes for Individual Patients

PROJECT SUMMARY/ABSTRACT
Patient-reported outcome measures (PROMs) are crucial for understanding the impact of cochlear implants (CIs)
on real-world functional abilities and for monitoring changes over time. However, CI clinical outcome measures
traditionally focus solely on CI users’ speech recognition ability, which lacks ecological validity, relies on
outcomes that are weakly associated with real-world functional communication ability, and disregards important
CI benefits such as improved social engagement and listening effort. Therefore, our current clinical practice
standards are not evidence based due to a critical knowledge gap that limits our understanding of the broad
functional impact of CIs on patients’ everyday lives. Improvement in speech recognition represents a
fundamental early step in the post-CI rehabilitation process. Further lasting real-world functional improvements
may occur but depend on how well CI users deploy their enhanced speech recognition skills in their everyday
lives. This two-phase process emphasizes the value of combining PROMs with measures of speech recognition
to comprehensively assess the patient-centered benefits of cochlear implantation. The enhanced rigor of modern
PROM development methodologies, as applied in the development and validation of the new Cochlear Implant
Quality of Life-35 Profile (CIQOL-35 Profile), have the potential to improve the monitoring of CI user progress
and inform clinical decision making. The proposed project includes a rigorous evaluation of the benefits of CIs
on a broad range of functional abilities conducted using a multi-site, longitudinal study design, which will provide,
for the first time, a comprehensive understanding of outcomes meaningful to patients and accomplish the
following Aims. Aim 1 will apply a novel CIQOL functional staging system, which provides real-world context to
CIQOL scores while maintaining the hierarchy of quantitative scores, in a group-based trajectory model to identify
clusters of patients in the longitudinal study who follow similar progressions through the CIQOL functional staging
system and identify patient factors associated with each trajectory cluster. Aim 2 will first determine the
magnitude of change in CIQOL-35 Profile scores considered clinically meaningful to CI users, then apply these
findings to better understand the association between early meaningful improvement after implantation and long-
term functional outcomes. Specifically, we aim to promptly identify patients at risk of poorer long-term outcomes
who may benefit from additional resources. Finally, Aim 3 will apply an implementation science approach to
translate the findings from our longitudinal study into clinical practice and enhance the integration of CIQOL
instruments into routine CI care. Together, the proposed research program will enhance the interpretation and
application of real-world CI outcomes for individual patients, inform patient discussions regarding expected
results and demonstrate the potential for PROMs to personalize and improve patient care.

Public health relevance
PROJECT NARRATIVE Cochlear implants (CIs) are the standard treatment for adults with moderate to profound sensorineural hearing loss who no longer benefit from hearing aids. This project enhances the interpretation and application of a new CI-specific quality of life measure so functional abilities can be tracked over time with the goal of improving hearing loss treatments for adults with moderate to profound hearing loss. This is directly relevant to the NIH’s mission as it seeks and applies knowledge to enhance human life.